Shared and novel contributors to risk of stroke and stroke recurrence in a multiethnic population – the role of social determinants of health, genetics, and epigenetics

Stroke is the second leading cause of death worldwide. In the United States, stroke is the fifth leading cause of death and a leading cause of serious, long-term disability. One quarter of strokes are recurrences. Recurrent strokes are more often fatal and result in even greater disability than first strokes in survivors. To date, few studies have focused on the interplay of social, epigenetic, and genetic factors in stroke and recurrent stroke risk. To address this knowledge gap, we will generate and evaluate DNA methylation data while leveraging genome-wide single nucleotide polymorphism (SNP) genotypic data and phenotypic data from individuals with stroke, recurrent stroke, or no stroke from the REasons for Geographic and Racial Differences in Stroke (REGARDS) study as well as participants from the Vitamin Intervention for Stroke Prevention (VISP) clinical trial. Expanding on our prior genetic and epigenetics studies, we hypothesize that we will identify DNA methylation sites and genetic markers influencing susceptibility for recurrent stroke and identify key social and environmental drivers that mediate stroke and stroke recurrence risk.
We will test our hypothesis by performing epigenome-wide association analyses for stroke and recurrent stroke risk including mediation analyses considering comorbidities, environmental factors, and biomarkers, generating genetic and epigenetic risk scores, and performing convergent -omics approaches. This represents a powerful and innovative technique to identify genetic and epigenetic contributors to stroke and recurrent stroke risk and may allow improved personalization of risk assessment and targeted prevention of strokes.

Public health relevance
Stroke has one of the most striking health disparities in the United States. Epigenetics can provide a lens through which to view how the environment and social factors interact with an individual’s unique genetic code to influence disease risk and outcomes. The goal of this proposal is to generate epigenetic data and leverage existing genomic and phenotypic data from the REasons for Geographic and Racial Differences in Stroke (REGARDS) study to identify unique and shared drivers of stroke risk and recurrence stroke risk to allow improved personalization of risk assessment and targeted prevention of recurrent strokes, while reducing the stroke disparities.